CONFOCAL MICROFLUOROMETRY & MICROSCOPY CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The COBRE Confocal Microfluorometry and Microscopy Core provides instrumentation, expertise, training and mentoring in confocal microfluorometry and microscopy. Capabilities include: microfluorometry of fast Ca2+ signals in cultured and native epithelial tissues, subcellular visualization of molecules, co-localization experiments where precise resolution and color separation through emission fingerprinting are necessary, and advanced co-localization techniques where emission scanning is critical.